RFA-CE-23-005, Pathways to firearm violence perpetration: The role of schools, social welfare, and justice systems during the formative school years.

PROJECT SUMMARY/ABSTRACT
The goal of this project is to conduct a longitudinal study of the school-to-prison pipeline to firearm violence
perpetration, with the overall objective to conduct research to inform opportunities to enhance safety and
prevent firearm-related injuries, death, and crime. In 2020, firearm-related homicides were the leading cause of
death among 15-44 year olds in the United States; and, in 2021, the number of Minnesotans who died from
gunfire reached its highest level in over 20 years. In addition to the substantial health burden, firearm violence
is an important element of youth involvement in the justice system. Firearm violence disproportionately impacts
underserved populations with BIAPoC (Black, Indigenous, Asian, People or Color) youth overrepresented in
the school discipline and justice systems, particularly in Minnesota which has one of the starkest racial/ethnic
disparities in the country. Yet, little is known about these trajectories to firearm violence perpetration. Couched
within the socioecological framework, we will first study the transition to firearm violence (i.e., time to firearm
violence perpetration) and trace how violent behaviors change and intensify over time. We will then examine
the effect of violence perpetrated within the school environment and associated disciplinary actions on future
involvement in the justice systems into early adulthood; how receipt of social welfare support during childhood
impacts future firearm-related violence perpetration focusing on economically disadvantaged youth; and how
this relationship might differ by race/ethnicity. Under Research Objective One and Funding Option A for RFA-
CE-23-005, we will conduct a longitudinal cohort study to follow 1.4 million children enrolled in K-12 public
schools in Minnesota for over 15 years and individually-linked to data from the court and human service
systems during their critical years of youth development. We will examine a comprehensive, multi-layer history
to characterize propagation to firearm-related violence, and the role of social welfare programs on this
trajectory. Our project utilizes linked individual-level, administrative data from the Minnesota Departments of
Education and Human Services, and the State Court Administrator’s Office. The findings will help inform the
development of promising opportunities to enhance safety and prevent firearm-related injuries, deaths, and
crime. Through this study, we will uncover important evidence regarding the first perpetration of firearm
violence, as well as persistence and desistance from such violence. In doing so, we will concentrate on the
precarious period of the formative school years, adolescence, and emerging adulthood. Our study will address
important research gaps regarding the school-to-prison firearm violence pipeline particularly among our most
vulnerable youth and evaluate how social welfare programs affect these trajectories.

Public health relevance
PROJECT NARRATIVE Firearm violence claimed over 48,000 lives in the United States in 2021, with the highest rates of perpetration among BIAPoC (Black, Indigenous, Asian, People or Color) youth. Youth are entangled within complex socioecological systems where, on one hand, violence occurs and, on the other hand, social safety nets like welfare programs exist. This research focuses on characterizing the school-to-prison firearm violence pipeline for the most vulnerable youth, measuring how early forms of school violence escalate to future firearm violence perpetration, and identifying how involvement with the social welfare system impacts these firearm violence trajectories.